ALOSETRON IN THE MEDIUM TERM TREATMENT OF PATIENTS WITH CARCINOID DIARRHEA

The purpose of this study is to compare the effectiveness of 3 doses of alosetron in the symptomatic treatment of pts with carcinoid diarrhea.